Dynamically-resolved structural studies of proteins from fungal and bacterial pathogens

Summary
Drug resistance and desensitization is a growing global concern. To overcome these therapeutic
issues, drug discovery pipelines have to make use of all available structural information to
generate novel, potent and safe therapeutics. Current medicinal chemistry efforts typically make
use of static, cryo-temperature protein structures, which do not integrate the dynamics known
govern protein function. Advancing from structure-activity to dynamic-activity relationships will
diversify the way we pursue drug discovery, opening doors to more advanced therapeutics. To
obtain this knowledge, the projects proposed will pursue time-resolved structural studies of
medically-relevant proteins from fungal and bacterial pathogens. Although challenging, time-
resolved structural biology has matured over the last decade making it amenable to a wider range
of protein targets. This research will break methodological barriers to swiftly obtain dynamic-
activity relationships, from which we will determine how dynamics correlate to protein function.
Complementary biochemical and biophysical studies will be used to unambiguously resolve
protein metastable intermediates. Methods such as photocaging and cryo-trapping are used to
trigger synchronize protein function in the sample, making use of the work and expertise of the PI
as well as the available facilities, including a dedicated organic synthesis laboratory.
Two initial targets will be pursued. The first one, C. Auris 3-Deoxy-D-arabinoheptulosonate 7-
phosphate Synthase (DAHPS) is an enzyme essential for fungal survival as it catalysis a step in
the biosynthesis of aromatic amino-acids. It is considered a promising drug target to current
antifungals and it is dynamically allosterically regulated. The second target is rubrerythrin from B.
pseudomallei, a protein believed to be responsible for oxidative stress responses for which the
mechanism is still unclear. Both projects will be targeted using an overarching methodological
pipeline which will generate new insights into dynamic-activity relationships and provide structures
of short-lived intermediates. Beyond the cutting-edge work proposed in this grant, these
discoveries will fuel a long-term research program focusing on harnessing dynamic information
to drive novel drug design.
The fundamental work proposed in this grant will fill gaps in our knowledge of protein mechanism
and its relationship to dynamics, and will pave the way to novel drug discovery approaches. The
proposed time-resolved experiments are challenging but made possible by the multi-disciplinary
expertise of the PI as well as strong collaborations that drive fertile scientific discussions and
unobstructed access to cutting edge technology and facilities in the USA and abroad.

Public health relevance
Project Narrative Visualizing the dynamics of medically-relevant proteins from pathogens during function provides critical insights into their activity and mechanisms, including regulation. By breaking the barriers to dynamically-resolved structural biology and applying cutting-edge methods, this work will expand our understanding on how protein conformational landscapes and their dynamics dictate protein function. The direct visualization of short-lived intermediates opens the doors to the design of novel, more precise drugs to combat emerging and difficult to treat infectious diseases.